The NEUROCITY Initiative: Empowering Underrepresented Scholars to Pursue Careers in Neuroscience

PROJECT SUMMARY / ABSTRACT
NEUROCITY is an innovative and transformational program hosted by the University of Rochester (UR) that
is focused on training promising undergraduate students from the City University of New York (CUNY), one of
the largest university systems in the United States that educates students from underprivileged and
underrepresented groups. The overarching goal of NEUROCITY is to develop well-rounded and technically-
skilled undergraduate researchers who are highly competitive for top-rated neuroscience PhD programs.
NEUROCITY emerged in 2021 from a partnership between faculty at UR and the City College of New York
(CCNY), one of the 25 colleges that comprise the CUNY system. In NEUROCITY, scholars engage in a hands-
on research training program in established laboratories at UR during the summer, and participate in a series of
career and professional development seminars and workshops that prepare students for navigating the many
challenges and barriers that are faced in graduate school. NEUROCITY has helped CCNY students make major
leaps into higher-end education, such as admissions to Ph.D. programs at R1 institutions. In this proposal, we
expand the NEUROCITY experience to provide more continuous research, mentoring, and career development
opportunities to all undergraduate students from the CUNY system. We build on the success of NEUROCITY
through three foundational aims: (1) Provide an immersive research and mentoring experience.
NEUROCITY Scholars actively participate in a series of research activities at UR that provides them with critical
research and analytical skills crucial for graduate school. (2) Provide a rigorous career development program.
NEUROCITY scholars participate in numerous seminars, workshops, and networking events that are critical for
their career and professional development. In particular, scholars will have the opportunity to attend the Society
for Neuroscience (SfN) annual meeting, and present their work at the Diversity Poster Session of SfN. (3)
Provide a continuous research and mentoring support network. NEUROCITY is unique in that it provides
research and mentoring opportunities beyond the summer, delivering a more sustained experience that sharpens
critical thinking and research skills, and leading to highly trained scholars who are more competitive for graduate
school. Through these continued research, mentoring, and career development experiences, our scholars
emerge as empowered and skilled professionals ready to make meaningful contributions to the field of
neuroscience at the graduate level.
Importantly, NEUROCITY employs a holistic selection approach to recruit students that have an excellent
track record in the classroom and at the bench, as well as those students who show promise in neuroscience
research, but have not had the opportunity to engage in research due to barriers in their personal lives (e.g.,
working after school to help support their households). As such, our selection process leads to a more inclusive
and representative cohort of students from underprivileged and underrepresented backgrounds.

Public health relevance
PROJECT NARRATIVE Students from underprivileged backgrounds and historically marginalized groups (typically underrepresented minorities) face significant cultural and socio-economic barriers that limit their ability to participate in transformative research experiences and to compete for PhD programs. This inequality hinders the careers of promising early-career biomedical researchers and has led to a substantial gap in diversity in the field of biomedicine, with more than 67% of the field comprising Non-Hispanic White scientists. Our immersive and inclusive summer research program, NEUROCITY, will serve as a critical instrument in closing this gap in diversity by equipping underrepresented early-career biomedical researchers with the mentorship, training, strategies, and networks necessary to pursue top-rated neuroscience PhD programs and navigate a career in biomedicine.